Investigating the Role of PSD-95 in Sleep in SHINE Syndrome

PROJECT SUMMARY
SHINE syndrome, a rare form of monogenic autism, is named for its key symptoms: sleep problems,
hypotonia, intellectual disability, neurological disorders, and epilepsy. This condition arises from an
autosomal-dominant mutation in the gene discs large MAGUK scaffold protein 4 (DLG4), which encodes
postsynaptic density protein 95 (PSD-95). PSD-95 is crucial for scaffolding, localizing, and stabilizing receptors
on excitatory postsynaptic membranes, thereby influencing synaptic strength and plasticity. The mechanism of
sleep problems in SHINE syndrome may be due to disruption of the molecular circadian clock and/or in
synaptic function. Previous work in our lab demonstrated that siRNA knockdown of DLG4 in cells results in a
shortened circadian period, suggesting that PSD-95 modulates circadian rhythms and contributes to the sleep
issues observed in SHINE syndrome. Our team has recently generated novel SHINE syndrome mice with a
patient-derived mutation, and these mice exhibit locomotor and sleep abnormalities. It remains unknown how
PSD-95, either through molecular or synaptic changes, impacts sleep and circadian processes. The
overarching goal of this proposed work is to elucidate the mechanisms behind sleep and circadian
disturbances in SHINE syndrome. With two related but independent aims, this proposal investigates: (i)
whether PSD-95 modulates circadian rhythms through tropomyosin receptor kinase B (TRKB)/mechanistic
target of rapamycin (MTOR) signaling, (ii) abnormalities in receptor levels and synaptic function in the
hypothalamus, and (iii) possible rescue of abnormalities with ketamine. Aim 1 proposes to determine whether
there is abnormal TRKB signaling in SHINE mice–resulting in subsequent abnormal MTOR activity–affecting
the cycling of the circadian clock protein BMAL1 in the hypothalamus. This will be accomplished by measuring
MTOR activity and BMAL1 cycling in the hypothalamus of SHINE mice at baseline, after chronic administration
of TRKB modulators (including ketamine), and following a washout period. The synchrony of molecular
rhythms will also be assessed. Aim 2 will then identify impairment in receptor composition and synaptic
function in the hypothalamus of SHINE mice. Sleep and epilepsy will be monitored by EEG, and levels of
AMPA and NMDA receptor subunits in the hypothalamus will be measured at baseline and after ketamine
administration. Collectively, the knowledge gained from this proposal has the potential to uncover disruption
caused by PSD-95 mutations and inform potential interventions to restore normal sleep and synaptic function
in patients with SHINE syndrome.

Public health relevance
PROJECT NARRATIVE Sleep problems are highly prevalent in patients with SHINE syndrome, but the mechanisms of this disruption are poorly understood. We demonstrated that knocking down DLG4–the gene mutated in SHINE syndrome–shortens circadian rhythms in cells, and our patient-derived SHINE mouse model exhibits abnormal locomotor and sleep phenotypes. Here we propose to leverage this model to better understand the impact of SHINE mutations on sleep.